Development Core

DEVELOPMENT CORE
SUMMARY
The overarching goal of the Development Core is to transform the capacity of our Center to conduct transdisciplinary, innovative, high-impact research on climate and health that addresses the needs of communities in the Midwest and Appalachia and to develop current and future workforce prepared to advance research on climate and health. Towards those ends, the Core’s three aims are to: 1) Enact a pilot grant program that provides competitive support for innovative transdisciplinary climate and health research; 2) Foster and
accelerate the professional development of early career investigators; and 3) Educate future leaders in climate and health. Under Aim 1, this Core will stimulate transdisciplinary research on health outcomes and potential intervention strategies pertaining to climate and health through a funding mechanism for pilot projects (“Urban Resilience Awards”); there will be five awards per year, providing up to $25,000 each year for transdisciplinary research pertinent to our central theme. Three of the awards will be supported from the P20 grant; an additional two will be supported by the University of Cincinnati under the same mechanism as a contribution to the development of this Center’s research capacity and productivity. Under Aim 2, the Development Core will address the pressing public health challenges posed by extreme weather events by supporting the recruitment, mentoring, research, and training of the next generation of scientists. The Core will competitively fund one career development award per year for an early-stage investigator, as well as tuition and stipends for two graduate students per year (contributed by the University) and Climate and Health scholarships
In summary, this Core supports the overall mission of the Center and introduces innovation by leveraging novel pilot grant mechanisms that catalyze interdisciplinary research and collaboration. At the same time, this Core will spearhead several innovative educational initiatives to cultivate the next generation of climate and health leaders. Ultimately, our approach to bridging disciplinary boundaries will empower a workforce (students, scientists, clinicians, and public health professionals) that is prepared to foster a resilient, health-conscious society in the face of extreme weather events.

Public health relevance
The DC addresses the pressing public health challenges posed by extreme weather events by supporting the recruitment, mentoring, research, and training of the next generation of scientists specializing in the health risks associated with extreme weather events. We introduce innovation by leveraging novel pilot grant mechanisms to catalyze interdisciplinary research and collaboration while spearheading several innovative educational initiatives to cultivate the next generation of leaders. Ultimately, our approach to bridging disciplinary boundaries will empower a multidisciplinary workforce (students, scientists, clinicians, and public health professionals) to foster a resilient, health-conscious society in the face of extreme weather conditions.